Structural Biology Shared Resource

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
STRUCTURAL BIOLOGY SHARED RESOURCE - PROJECT SUMMARY/ABSTRACT
The Structural Biology Shared Resource (SBSR) supports a wide range of technologies for identifying new
targets, defining molecular mechanisms, and generating tool compounds and therapeutic leads. Services
include: 1) state-of-the-art protein production; 2) high resolution structure determination by X-ray crystallography,
NMR and cryo-EM; 3) mass spectrometry-based proteomics analyses; and 4) additional advanced technologies.
SBSR provides access to state-of-the-art infrastructure located in-house and at regional centers and national
laboratories to support the scientific priorities outlined in the MECC Strategic Plan. Protein-based tools facilitate
the mechanistic dissection of fundamental biological and pathological processes, and the validation of potential
therapeutic strategies in cell- and animal-based disease models. Mass spectrometry and proteomics enables
the discovery of new targets and biomarkers, and provides deep mechanistic insight into responses associated
with disease states and treatment regimens. Structural data provide atomic-resolution insight for protein design
and medicinal chemistry essential for enhancing initial hits and lead therapeutics. The SBSR Specific Aims are:
Aim 1: Provide state-of-the-art technologies for protein expression, purification and characterization, and
validation. These resources include bacterial, insect cell, and mammalian cell expression platforms supported
by considerable automation to facilitate these efforts. SBSR staff provide the full range of support services,
including construct design and downstream characterization.
Aim 2: Enable high resolution structural characterization. Available resources include in-house capabilities in
NMR, X-ray crystallography and cryo-EM, as well as extensive access to state-of-the art national facilities for
NMR and cryo-EM (New York Structural Biology Center) and X-ray crystallography (Brookhaven National
Laboratory and Argonne National Laboratory). SBSR staff provide the full range of support services, including
data collection and processing, structure determination, validation, and structure interpretation.
Aim 3: Provide state-of-the-art mass spectrometry capabilities for proteomics analyses, including protein
abundance, determination of regulated protein pathways and other networks, identification and quantification of
protein post-translational modifications and protein synthesis rates. SBSR staff provide the full range of support
services, spanning experimental design, sample preparation, data acquisition and data interpretation.
The breadth of core services supports the entire spectrum of investigators, and the extensive coordination among
the SBSR leaders allows for the seamless movement among core-supported technologies. As such, projects
can enter the pipeline at any stage. For example, inexperienced investigators can enter the pipeline at the protein
expression stage and receive support all the way through structure determination and interpretation.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward STRUCTURAL BIOLOGY SHARED RESOURCE - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page